Development of TLR5 agonist based approaches to boost chemo-immunotherapy by modulating immunosuppressive networks

ABSTRACT
Certain mouse and human cancers stimulate profound expansion of a type of highly immunosuppressive immune
cell called polymorphonuclear myeloid-derived suppressor cells (PMN-MDSCs). These cells potently inhibit
antitumor immunity and thus remain a significant barrier to the efficacy of immunotherapy-based treatment
modalities for cancers that induce PMN-MDSCs. Mouse and human breast cancer including the triple negative
subset (TNBC) is one such cancer that efficiently expands PMN-MDSCs, which negatively correlates with clinical
outcomes in FDA-approved chemo-immunotherapy (CTx-I) protocols for a particular TNBC subset that
expresses PD-L1. Unfortunately, efforts to improve CTx-I strategies for PMN-MDSC inducing cancers by
therapeutically targeting these cells have proven unsuccessful. To this end, we found that our clinical-stage
immunotherapy drug called entolimod stimulates antitumor immunity against metastatic 4T1, a well-recognized
pre-clinical PD-L1+ TNBC tumor model that expands PMN-MDSCs. In fact, we found that entolimod stimulates
antitumor immunity against 4T1 in part by diminishing the immunosuppressive activity of PMN-MDSCs.
Moreover, mirroring the CTx-I protocols used to treat patients diagnosed with PD-L1+ TNBC, we found that
entolimod boosts antitumor efficacy of CTx-I against 4T1, albeit, through unresolved mechanisms. Despite these
findings in pre-clinical PD-L1+ TNBC, to what extent these findings translate to human PMN-MDSCs in breast
cancer patients and implications of these findings for boosting CTx-I in cancer patients remain unclear. Thus,
this proposal seeks to uncover the mechanistic underpinnings by which entolimod dampens PMN-MDSC activity
in both mice and humans in order to fuel the design of improved CTx-I therapies for those cancers in which
efficacy is hindered by PMN-MDSC expansion including PD-L1+ TNBC. And in this regard, entolimod has
successfully completed Phase I safety trials cumulatively involving nearly 200 subjects including healthy
volunteers and cancer patients thus facilitating the clinical translation of entolimod with CTx-I protocols.

Public health relevance
PROJECT NARRATIVE Certain mouse and human cancers induce profound expansion of immunosuppressive polymorphonuclear myeloid-derived suppressor cells (PMN-MDSCs), which potently inhibit the efficacy of chemo-immunotherapy (CTx-I) protocols. Our clinical-stage immunotherapy drug called entolimod can both dampen PMN-MDSC activity and boost CTx-I efficacy in 4T1, a well-recognized pre-clinical model of PD-L1+ triple negative breast cancer (TNBC) that expands PMN-MDSCs. This proposal seeks to uncover the mechanistic underpinnings by which entolimod dampens PMN-MDSC activity in both mouse and human TNBC in order to fuel the design of improved CTx-I clinical protocols for those cancers in which efficacy is hindered by PMN-MDSC expansion including PD- L1+ TNBC.